Technologies to enable safe and effective gene editing in skeletal muscle

Gene editing is moving towards the clinic, but several challenges must be addressed in order for it to be applied
to skeletal muscle disease. Adeno-associated virus (AAV) is one of the most promising technologies to enable
delivery of gene editing machinery to skeletal muscle, but at least four major hurdles stand in the way of using it
to safely and effectively edit genes in this tissue. These include 1) maximizing delivery of editing enzymes to
muscle, 2) maximizing spread of editing enzymes across nuclei of the myofiber syncytium, 3) avoiding sustained
expression of editing enzymes, and 4) integrating solutions to each of these problems in a single AAV so as to
minimize total viral dose required. Given that exciting new myotropic capsids that have emerged in the literature,
this proposal is primarily focused on addressing the latter 3 issues. We have previously developed ways to
shuttle Cas enzymes throughout myofibers and now propose to use creative new approaches that rely on tried-
and-true mechanisms to access and edit even more myonuclei in skeletal muscle. We have also developed ways
to use small molecules to control AAV-delivered gene expression and propose to further develop this technology
to achieve fully “off” transgene states with maximally “on” states when desired, so that Cas enzyme expression
can be turned off when no longer needed. Finally, we will integrate these technologies with the latest miniaturized
Cas enzymes and package all components, including guide RNAs, into a single AAV vector. We will test
approaches in mouse models of myotonic dystrophy and Duchenne muscular dystrophy. Ultimately, the insights
we make here will be apply to gene editing for any skeletal muscle disease and enable the next generation of
therapies for muscular dystrophies.

Public health relevance
The proposed research is relevant to public health as it develops enabling technologies for gene editing in skeletal muscle. Current rates of gene editing in this tissue are low and methods are lacking for how to control expression of gene editing enzymes in this tissue. We will develop new technologies to 1) edit as many myonuclei as possible in the context of the myofiber syncytia, 2) control expression of gene editing enzymes, and 3) integrate these elements into a single gene therapy vector.